Center for Demography and Ecology

Overall Component
Project Summary/Abstract
This application requests five years of support for the Center for Demography and Ecology (CDE) at the
University of Wisconsin–Madison. CDE is a highly-productive population research center, with 70 affiliates in
21 departments across four colleges conducting work that directly addresses the three components of the
Population Dynamics Branch scientific mission. CDE has held NICHD center grant funding continuously since
1972, and this application requests continuation of that support under NICHD's Population Dynamics
Research Infrastructure Program (P2C). Support is requested for an Administrative Core, a Development Core,
and a Scientific and Technical Core. The center grant would support an integrated and interdisciplinary
collection of scholars whose research spans the field of population science. During the past five years, CDE has
recruited a large number of excellent young scientists and established scholars and strengthened its ties across
campus with departments, research centers and institutes in fields related to CDE's research areas. Our
research portfolio is now more diverse, more interdisciplinary in character, and covers a greater portion of the
life course than in the past. CDE affiliates conduct research in five primary research areas: (1) Fertility,
Families and Households; (2) the Demography of Inequality; (3) Health and the Life Course; (4)
Biodemography; and (5) Spatial and Environmental Demography. In addition to innovative research in each of
these areas, CDE researchers continue to collect and produce high-quality data for use by the population
research community, including a growing body of genetic and biomarker data. Continued infrastructure
support from NICHD will allow CDE to leverage substantial commitments from the University, a large portfolio
of individual research grants, and outstanding human and organizational resources to promote innovative
interdisciplinary research in population science.

Public health relevance
Overall Component Project Narrative Population science plays a critical role in identifying changing population patterns and their implications for individuals, groups and societies. Increasingly, with new data and analytic techniques, population science is able to bridge social scientific, biomedical and environmental research in order to better understand the multiple and interactive factors that affect human health and wellbeing. CDE will continue to conduct, develop and disseminate innovative, interdisciplinary population research and to provide excellent training to the next generation of scholars.